CONSENT FOR INVOLVEMENT IN ENVIRONMENTAL &GENETIC STUDIES

This study is aimed at identifying structural pediatric cardiac abnormalities within the state of Wisconsin, cataloging these disorders, obtaining information regarding the temporal, environmental and familial basis of the disorder, obtaining genetic information on family members and subsequently probing the data to identify common characteristics and genetic basis for the occurrence of the disorder.